Interest, Preference, and Uptake of Long Acting ART among PLWH in Florida

Project Summary
A newly approved long-acting injectable (LAI) form of antiretroviral therapy (ART) is now available, and several
other long-acting formulations are in development. These provide new tools to achieve the ambitious goals
described in the initiative to End the HIV Epidemic in the United States by helping more people living with HIV
(PLWH) achieve durable viral suppression. Because alcohol use is associated with decreased adherence,
these treatments may be especially helpful among PLWH who drink. The impact of these exciting new
treatments will be proportional to their uptake, which will be affected by both individual preferences and
systemic factors. Previous studies have shown high levels of interest in LAI-ART but have not generally
accounted for systemic factors that may hinder LAI-ART uptake. The long-term goal of the proposed research
is to inform programs to improve ART adherence for PLWH. To help achieve this goal, the aims of this F31
grant are to: 1) determine which individual- and interpersonal-level factors are associated with preferences for
a quarterly LAI-ART over taking daily pills in PLWH, focusing on populations with lower ART adherence and at-
risk drinking, using existing data from the Florida Cohort study; 2) describe PLWH’s preferences for long-acting
ART (LA-ART) formulations and determine which treatment attributes drive these preferences by implementing
a best-best discrete choice experiment and explore whether preferences vary by drinking status and viral
suppression; and 3) to conduct in-depth qualitative interviews with 20 stakeholders involved in HIV medication
procurement and prescribing (e.g., HIV-care providers and clinician administrators) to gain insight into their
attitudes towards and prescribing preferences of different LA-ART formulations, how these are impacted by
patients’ alcohol use, systems-level barriers and facilitators of prescribing LA-ART, and how these visits can be
used to increase the accessibility of alcohol-related care. Conducting this study will help me develop cross-
cutting skills to achieve my long-term career goals of designing programs to improve health outcomes for
PLWH, especially those who drink by focusing on: 1) measuring of individual preferences and decision-making
related to health, 2) obtaining expertise in qualitative data collection and analysis, 3) gaining a better
understanding of public healthcare financing related to HIV treatment and substance use, 4) learning skills
related to professional and career development, and 5) responsible conduct of research. This study will
leverage the ongoing Florida Cohort study, which is enrolling a diverse population of adult PLWH, and
collaborations between Southern HIV and Alcohol Research Consortium and the Florida Department of Health
and HIV care providers. These data can inform funding allocation and policy changes to support these ART
preferences and can be extrapolated to treatments for alcohol and other substance use disorders to help focus
development of novel medications or develop programs to help better integrate HIV care and alcohol-related
treatment.

Public health relevance
Project Narrative This study will yield valuable information on factors that will influence the uptake of new and in-development antiretroviral therapy (ART) for people living with HIV, including individual treatment preferences and the perceptions of HIV-care providers and other stakeholders in HIV care programs. Because alcohol use is associated with worse HIV-related health outcomes, a key focus of this study will be how alcohol use influences individual preferences and prescribing practices as this population could benefit greatly from long- acting formulations of ART. These data can help better target ART formulation development and guide funding and procurement practices in organizations and programs that provide HIV-related care.